Role of Complement Receptor Activation in a Mixed Dementia Model

The coexistence of Alzheimer (AD) and cerebrovascular disease (CBVD), which defines Mixed Dementia
(MxD) is present in many, if not most, of those diagnosed with AD. Hypertension is the major risk factor
contributing to CBVD, driving small vessel disease (SVD), associated with white matter (WM) lesions
characteristic of MxD, but the paucity of MxD models limits progress to understand mechanisms and advance
therapeutics for this common disease. For example, drugs developed to clear amyloid (Abeta) may exacerbate
CBVD, and fail to target poorly understood synergism between AD and CBVD. Our novel rat MxD model exhibits
coexisting vascular and AD pathologies (AD transgenic), whereby hypertension and SVD exacerbate AD-
associated aberrant neuroinflammation, mitochondrial dysfunction and tauopathy (Denver et al. 2019). Since
recent clinical data, showing that WM damage is associated with the spread of tauopathy, not Abeta (Kapasi et
al., 2022), this further validates our model. Further new data on seeding of MxD rats with tau fibrils, recapitulates
tau spreading seen in human AD/MxD. The model was produced by breeding the Tg AD into a SHR-Stroke
prone (SHRSP) rat background, the most widely studied model for vascular cognitive impairment and SVD,
which exhibits a compromised neurovascular unit. Unlike mice, rats express all 6 tau isoforms and are more
suitable than mice for complex imaging and behavioral testing, and assessing fluid biomarkers. The central
hypotheses are: a) Complement factors are major components synergistically driving MxD and AD, and b) there
is a positive feedback loop between tau pathogenesis and complement activation such that antagonizing either
tau aggregation with structure-based inhibitors (Aim 2) or the complement cascade (Aim 3) will disproportionately
reduce WM damage, tauopathy and executive function deficits in the hypertensive MxD model. Aim 1 will identify
key MRI and laser captured pathology RNA expression profiles. 1A examines longitudinal changes of
translatable MRI imaging measures (including SVD, demyelination, atrophy, and BBB leakage) that distinguish
MxD from AD. In 1B, we perform IHC-guided laser capture microscopy dissection (LCM) and RNA seq in
these MRI-characterized rats in 3 regions representing increased tauopathy (hippocampus),
demyelination/WMH (dorsolateral/prefrontal cortex) and SVD (thalamus/putamen) to define MxD-specific, lesion-
related pathways. Aims 2 and 3 investigate how AD and hypertension interact to influence a positive feedback
loop between complement and tauopathy. Aim 2 uses a structure-based tau aggregation inhibitor that we
characterized in tau mouse models. Aim 3 uses a state-of-the-art orally bioavailable and brain penetrant small
molecule inhibitor (see letters), to investigate the causal role of C5aR activation that can drive tauopathy, BBB
breakdown and WM loss. Outcomes. Outcomes focus on regional biochemical and histological changes in BBB,
myelination, neurodegeneration, neuroinflammation and executive function deficits. CSF/plasma biomarkers are
assessed: specifically validated AD biomarkers (ptau, NFL, Abeta40/42) and those associated with brain
inflammation (GFAP, AQP4 (astrocytic endfoot protein)) or WMH (complement factors C3b, and Bb) and
neuroprotection (BDNF) to identify their role in the tau-complement C5a feedback loop. Interpretation: Advances
may include demonstration of hypertension-enhanced tauopathy and/or C5aR and tauopathy-enhanced BBB
breakdown and one or more effective new treatments. Alternatively, tau aggregate inhibitors may not impede
BBB and inflammatory pathogenesis, suggesting a minor role for the tau-inflammation-BBB loop and arguing for
combination therapies. Which upstream C3-related inflammatory or downstream C5b components are inhibited
by C5aR inhibitors will provide important insight into tau-complement feedback interactions in MxD. RNAseq is
likely to fill major knowledge gaps in understanding mechanisms of SVD that drive conversion from AD pathology
to onset of cognitive decline. Our proposal is strengthened by a multidisciplinary team with expertise in stroke,
MRI imaging, LCM /RNAseq, complement activation, CBVD/AD neuropathology, and executive dysfunction.

Public health relevance
Uncontrolled hypertension is present in 37% of veterans, posing several risks to health, including cerebrovascular disease (CBVD) which increases the risk for Alzheimer’s dementia (AD). In fact, 80% of AD patients have some degree of CBVD, which can worsen response to drugs designed to target pure AD, which may be one reason why billions of dollars of investiment in drug development for dementia has had little impact on therapies. In addition to the 750,000 veterans who currently have dementia, there are predicted to be nearly 900,000 new cases by 2030, so we validate a new animal models and test two drugs to understand how to treat the complexity of this devastating disease which has a catastrophic toll on Veteran patients and their caregivers, global health, Medicare and the US economy and Federal budgets that fund the VA.